A cell model of YARS2-associated childhood-onset mitochondrial disease

PROJECT SUMMARY
We hypothesize that pathogenic variants in the family of the nuclear ARS2 genes, encoding mitochondrial
aminoacyl-tRNA synthetases (mt-aaRSs), cause disease primarily by disrupting nutrient sensing and cell
signaling. Each mt-aaRS is responsible for charging its cognate mitochondrial tRNA (mt-tRNA) with its specific
amino acid, as required for the dedicated mitochondrial protein synthesis machinery. Loss-of-function variants
of each ARS2 have been linked to human diseases, showing central nervous system involvement, myopathy,
sensorineural hearing loss, ovarian dysgenesis, and pulmonary hypertension. However, the correlation is poor
between the enzymatic activity of individual variants and manifestation of the disease phenotypes. This suggests
that disease is mediated not necessarily via loss of tRNA charging, but by other functions of mt-aaRSs. Given
that the cytosolic counterpart ARS1 genes are often implicated in non-canonical functions, beyond
aminoacylation, we will test the hypothesis that ARS2s mediate nutrient-sensing and cell-signaling processes
that are disrupted by pathogenic variants resulting in disease development. To test this hypothesis, as a pilot
model, we will generate a human subject-derived induced pluripotent stem cell (iPSC) line with pathogenic
variants in the YARS2 gene, encoding mt-TyrRS. Pathogenic variants of YARS2 result in the MLASA (myopathy,
lactic acidosis and sideroblastic anemia) syndrome. Previous studies of pathogenic YARS2 variants have shown
no appreciable effect on tRNA aminoacylation. Here we focus on a pair of novel compound heterozygous
mutations that we identified in a human subject with neonatal fatal disease, the most severe clinical case
observed to date. This provides a unique model where the largest changes in nutrient sensing and cell signaling
are expected to occur. In Aim 1, we will create an iPSC line from an established fibroblast line of the human
subject. We will use CRISPR/Cas to generate an isogenic control line that corrects the genetic mutations. In Aim
2, we will differentiate the patient and control iPSC lines to disease-relevant cell types. We will focus on myocytes,
as skeletal myopathy is the most notable feature of clinical cases of YARS2 variants. We will also focus on
peripheral neurons, which are affected in most clinical cases of other ARS2 variants. We will identify changes of
gene expression in nutrient sensing or cell signaling of the subject line. Combined, this work will produce an
isogenic pair of subject and control iPSC lines that will be shared with the research community. This pair of iPSC
lines will serve as the foundation for understanding the implications of nutrient sensing and cell signaling in
YARS2 variants, which will provide a template that is generalizable to other ARS2-associated disease.

Public health relevance
PROJECT NARRATIVE Childhood-onset mitochondrial disease associated with mutations in YARS2 is clinically pleiotropic, likely due to tissue-specific effects of mutations on nutrient sensing and cell signaling. To test this hypothesis, we will use the most clinically severe case known to date as a model to generate a pair of human subject-derived iPSC and control lines. Analysis of transcriptome-wide changes in gene expression specific to the subject line in iPSC- differentiated disease relevant cell types will identify the impact of YARS2 deficiency on nutrient-sensitive cell signaling as the underlying basis of the disease.